Determining how neutrophil activities contribute to antibiotic treatment failure

The battle against bacterial infections is pivotal to modern medicine, allowing for safe medical procedures
ranging from surgeries to organ transplants. However, despite the arsenal of effective antibiotics available,
treatment failures persist in the absence of detectable antibiotic resistance, posing a significant challenge in
the clinical management of diseases like Staphylococcus aureus bacteremia. S. aureus infections, despite
showing in vitro sensitivity to common antibiotics such as vancomycin and daptomycin, often require prolonged
treatments in vivo, with a substantial fraction of treatment failures attributed to poorly understood mechanisms
of antibiotic tolerance.
Our research aims to dissect the role of neutrophil extracellular traps (NETs) in promoting antibiotic tolerance in
S. aureus. We hypothesize that NETs modulate bacterial metabolism, thereby enhancing bacterial survival
against antibiotic treatments. We propose to explore the mechanisms underlying neutrophil-induced antibiotic
tolerance and the potential therapeutic benefits of inhibiting NETosis through targeted interventions.
This study is structured around two specific aims: First, we will delineate the mechanism through which
neutrophils induce antibiotic tolerance in S. aureus. We will evaluate the role of NETosis in antibiotic tolerance
using the NETosis inhibitor Cl-amidine and assess the contributions of various neutrophil effectors like DNA,
calprotectin, myeloperoxidase, and antimicrobial peptides. Additionally, we will measure S. aureus metabolic
responses such as ATP levels and respiratory activity in the presence of purified NETs. Second, we will
investigate the impact of inhibiting neutrophilia and NETosis on the efficacy of antibiotics in a murine
bacteremia infection model, using B6 mice treated with Anti-Ly6G antibodies to deplete neutrophils and PAD4-/-
mice, deficient in NETosis. Furthermore, the effectiveness of dexamethasone in enhancing antibiotic clearance
will be evaluated.
Understanding the mechanisms that underlie antibiotic tolerance in vivo is crucial for addressing the high rates
of treatment failure in bacterial infections. Our study aims to uncover the role of neutrophils and NETs in this
context, potentially leading to novel therapeutic strategies that combine immunotherapy with traditional
antimicrobial treatments to improve outcomes in bacterial infections. This could significantly impact clinical
practices by reducing the duration of antibiotic therapies and reducing the evolution of antibiotic resistance.

Public health relevance
Antibiotics frequently fail in the treatment of S. aureus bacteremia, even in the absence of resistance. Here, we will decipher how neutrophils, a major component of the innate immune response to S. aureus infection, inadvertently induce an antibiotic tolerant state in the pathogen, strongly contributing to antibiotic failure. Identification of components of the immune response that hamper antibiotic efficacy will open the door to new immunomodulation approaches to improve treatment of bacterial infection, mirroring developments seen in the treatment of cancer and viral infection.